Modulation and exploitation of Siglec-6 function to broadly impede mast cell activation

PROJECT SUMMARY
Mast cells are essential cellular effectors of a number of allergic and non-allergic diseases and conditions,
ranging from anaphylaxis to pseudoallergic drug responses and chronic spontaneous urticaria to systemic
mastocytosis. Therapeutic options for human mast cell-driven diseases and conditions generally focus on
ameliorating symptoms rather than disease modification or cure, and many remain incompletely effective. In
addition, because a number of different receptors may induce deleterious mast cell activation, a broadly
applicable inhibitory strategy would offer far-reaching clinical benefits.
Sialic acid-binding immunoglobulin-like lectin (Siglec)-6, a member of a receptor family characterized by binding
to glycan chains that terminate with sialic acid, is highly, uniformly, and selectively present on human mast cell
populations. Many Siglecs, including Siglec-6, possess cytoplasmic ITIMs and ITIM-like motifs and exhibit
inhibitory activity when engaged. Indeed, we have shown that Siglec-6 can reduce mast cell activation through
the IgE receptor, Mrgprx2, and C5aR upon ligation, presumably through the recruitment of inhibitory signaling
proteins like protein tyrosine phosphatases to its cytoplasmic ITIM. Generally, however, ITIM-bearing receptors
usually do not prevent cellular activation without co-associating with the relevant activating receptor. In addition,
the abundant and selective expression of the receptor on human mast cells makes it an ideal target through
which to deliver therapeutic cargo into mast cells. The overall goal of this proposal is to exploit the biology of
Siglec-6 to prevent or treat mast cell-driven diseases or conditions. This concept will be explored in studies
dedicated to understanding the signaling pathways initiated by ligation or co-ligation of Siglec-6 as well as the
functional consequences of Siglec-6 upregulation on mast cells (Aim 1), understanding the endocytic pathway
utilized by Siglec-6 and exploiting this pathway to deliver toxic cargo to malignant or disease-promoting mast
cells (Aim 2), and exploiting Siglec-6 antibody engagement or co-engagement with activating receptors to
prevent or treat harmful mast cell responses (Aim 3). A unique toolkit has been amassed to complete this study,
including primary skin-derived human mast cells, human CD34+ cell-derived mast cells, human mast cell lines
(HMC-1.2, LAD2, and ROSA KITD816V), cell lines transfected with Siglec-6 or mutants lacking an intact ITIM
and/or ITSM, mice engineered to express human Siglec-6 in the mast cell compartment (driven by the Mcpt5 or
Cpa3 promoters), liposomes bearing a neoglycolipid ligand of Siglec-6, and streptavidin complexes bearing anti-
Siglec-6 mAb as well as agents targeted to various activating receptors found on mast cells. Experiments
deploying these unique assets will provide mechanistic insight into the biology, signaling, pharmacology and
immunology of the Siglec-6 receptor as a selective human mast cell target.

Public health relevance
PROJECT NARRATIVE: The goal of this research study is to examine the biology and efficacy of Siglec-6 in reducing or preventing mast cell activation via several distinct stimulatory pathways and delivering therapeutic cargo selectively to mast cells both in vitro and in several mouse models of mast cell-dependent diseases, incorporating transgenic mice expressing the human Siglec-6 receptor and humanized mice bearing a human mast cell line. Siglec-6, as a receptor found at high levels on human mast cells in the skin, lung, adipose tissue, and colon and on all mast cell lines that we have analyzed and on few other hematopoietic cells, offers critical advantages over the related receptor Siglec-8, which we have studied as a target on eosinophils and mast cells, but which is not as selectively or consistently expressed on mast cells and is not as effective in inhibiting mast cell activation. Knowledge of the signaling and endocytic pathways of the receptor, as well as the efficacy of distinct approaches to mast cell targeting in vitro and in vivo, would provide important insights into potential treatments of diseases and conditions involving mast cells, such as anaphylaxis, pseudoallergic drug reactions, mast cell-dependent cutaneous inflammation, and systemic mastocytosis, for which there is a clinical need for disease-modifying or curative therapeutic approaches.